IMPLEMENTATION OF MULTIDISCIPLINARY STANDARDS IN THE EMERGENCY DEPARTMENT

This CDMAS project analyzes pre and post test measurements of job satisfaction, patient factors and specific patient outcome measures after implementing patient care standards.